Regulatory mechanisms for nuclear cGAS

Project summary
Excessive DNA from either the pathogen or host activates the cytosolic DNA sensor, cyclic GMP-AMP
synthase (cGAS), which produces the second messenger, cyclic GMP-AMP (cGAMP), initiating a signal
cascade leading to the expression of type I interferon (IFN). Although initially considered a cytosolic protein,
recent studies reveal abundant expression of cGAS in the nucleus, tethered to chromatin throughout the cell
cycle. Despite the nucleosome binding model clarifying the inactivity of nuclear cGAS, many unresolved
questions persist. Foremost among them is the crucial query regarding the immunological significance of
nuclear cGAS in the DNA-rich environment. Furthermore, the mechanisms underlying the entwining of cGAS
into chromatin and the regulation of this process remain unclear. The possibility of nuclear cGAS activation
poses another unanswered question, prompting exploration into how and under what physiological or
pathological conditions this might occur. Lastly, the activation of cGAS in micronuclei originating from the
nucleus is yet to be fully elucidated. Thus, this application is to define the role of nuclear cGAS in the DNA
sensing signaling pathway and elucidate the regulatory mechanisms of nuclear cGAS. Based on the existing
literature and our preliminary data, we hypothesize that nuclear cGAS is an immune sensor for
heterochromatin perturbation. We will investigate three overarching aims. Aim 1 will determine the
mechanisms that control cGAS nuclear localization and activation. Aim 2 will determine the mechanisms by
which nuclear cGAS senses DNA viruses. Aim 3 will determine the mechanisms controlling nuclear cGAS
activation upon DNA damage.
Our model proposes that nuclear cGAS is the sensor that elicits an immune alarm by detecting the dangers of
heterochromatin perturbations caused by various cell insults, such as viral infection and genotoxic stress. If our
hypothesis is correct, this new model will bridge the gaps in understanding the biological significance of
nuclear cGAS. Furthermore, such knowledge can be harnessed to rationally intervene in cGAS signaling to
boost or dampen innate immune responses in infectious diseases, autoinflammatory diseases, and cancers.

Public health relevance
Project Narrative Viral DNA and host DNA from cellular damage induce interferon, which plays a major role in host defense against DNA viruses and autoimmune diseases, such as systemic lupus erythematosus. Our study will bridge the gaps in understanding the role of DNA sensor nuclear cGAS in host innate immune responses. The results of this study offer the potential to develop new therapeutics for infectious and autoimmune diseases.